The Tumor Microenvironment Niche of Type I conventional Dendritic Cells

PROJECT SUMMARY
This study investigates the ‘reactive’ immune system in tumors, namely the cellular and molecular allies that
allow immunotherapies to work. In the previous cycle of this funding, we discovered that one set of intratumoral
dendritic cells type 1 (cDC1) present tumor antigens to T cells and that natural killer cells provide critical Flt3L to
cDC1 cells within reactive tumor microenvironments. The overall hypothesis of this proposal is that reactive
tumor immunity, based on CD8 T cells and those cDC1, has an archetype and a niche—a collection of cell
types that organize and support it. By defining those cells, their associated genes and their relationships, we
will be in a position to better create this niche and to thus engineer tumor clearance.
This program is unique in applying spatial transcriptomics together with genetic tools and conventional cellular
immunoassay methods to understand the critical phenotype-biology relationship between critical cDC
populations and their partners. The resultant discoveries will be formative for designing new ways to boost anti-
tumor immunity.

Public health relevance
PROJECT NARRATIVE Some patients’ immune system can be triggered with immunotherapies, leading to their cure. Those patients have a collection of ‘reactive’ immune cells in their tumors, and this proposal will figure out how to support that immune system so that even patients without those cells can be cured.